CNS Demyelinating Autoimmunity Targeting Water Channel Complexes

DESCRIPTION (provided by applicant): Water channels are a newly recognized target for CNS inflammatory autoimmune demyelinating diseases. Neuromyelitis optica (NMO; aka optic spinal multiple sclerosis [MS]) is a devastating disease that disproportionally affects non-Caucasians. It is characterized by recurrent episodes of optic neuritis and transverse myelitis, resulting in blindness and paraplegia in most patients, and it is frequently misdiagnosed as MS. Contrary to traditional teaching, NMO is not rare. It is the first MS-like disease for which a specific antigen has been identified--the astrocytic water channel aquaporin-4 (AQP4). This discovery represents a seismic shift from historic emphasis on the oligodendrocytes and myelin. An autoantibody specific for AQP4 (NMO/AQP4-IgG) is a clinically validated serum biomarker that distinguishes relapsing NMO from MS, which has no distinguishing biomarker and calls for different therapies. We suspect that a significant proportion of patients who are severely disabled (i.e., blind or paraparetic) from presumed MS, particularly African Americans, carry a misdiagnosis and will prove to be NMO/AQP4-IgG seropositive. Despite the high sensitivity and specificity of NMO/AQP4-IgG for NMO, the relationship of serum level to disease severity has not been established. We anticipate that qualitative and quantitative bioassays corresponding to distinctive pathologic outcomes of NMO/AQP4-IgG interacting with AQP4 in living target cells may predict clinical outcome. Our cumulative clinical, therapeutic and immunopathologic observations suggest that NMO patients who test negative for NMO/AQP4-IgG nevertheless have an antibody-mediated disorder. Our preliminary data support the existence of alternative pathogenic NMO-IgGs targeting novel components of the astrocytic AQP4/dystroglycan complex. We aim to 1) determine the prevalence of NMO/AQP4-IgG in serum of ethnically diverse patient cohorts and store DNA for future use in genetic correlative analyses; 2) assess the predictive and prognostic value of immunochemical, functional (complement activation, AQP4 downregulation and coupled glutamate transporter downregulation) and biosensor NMO/AQP4-IgG assays (indicative of antibody concentration and affinity) and 3) search for and validate novel IgG biomarkers (NMO-IgG X1, X2, ...) as the potential basis of NMO in apparently seronegative patients. Knowledge of the frequency of AQP4 autoimmunity, correlation with ethnicity and frequency of MS misdiagnosis will impact health care delivery and economics. Positive correlations of NMO/AQP4-IgG (titer, concentration/affinity and functional in vitro effects) with clinical or radiologic outcomes are anticipated to reveal prognostic antibody profiles as basis for appropriate therapy. Advanced serological interpretive insights, coupled with identification of alternative diagnostic markers (i.e., new NMO-IgGs reactive with AQP4 partner proteins in the dystroglycan complex) may lead to formulation of individual patient-specific NMO therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Antibodies directed at astrocytic water channels (aquaporin-4) in the central nervous system (CNS) represent a new direction in research of a severe inflammatory demyelinating CNS disorder that often results in blindness, confinement to a wheel chair and terminal respiratory failure. This study aims to 1) determine the frequency of autoantibodies targeting aquaporin-4 or its partner proteins and how often this condition is misdiagnosed and mistreated as multiple sclerosis and 2) identify laboratory tests that aid its diagnosis, predict outcome and lead to new therapeutic targets. PROJECT NARRATIVE Antibodies directed at astrocytic water channels (aquaporin-4) in the central nervous system (CNS) represent a new direction in research of a severe inflammatory demyelinating CNS disorder that often results in blindness, confinement to a wheel chair and terminal respiratory failure. This study aims to 1) determine the frequency of autoantibodies targeting aquaporin-4 or its partner proteins and how often this condition is misdiagnosed and mistreated as multiple sclerosis and 2) identify laboratory tests that aid its diagnosis, predict outcome and lead to new therapeutic targets. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS In 2004 and 2005, the Mayo Neuromyelitis Optica (NMO) Consortium identified and validated the first specific autoantibody marker for any inflammatory central nervous system (CNS) demyelinating disorder. Originally named NMO-IgG, it is specific for aquaporin-4 (AQP4), the principal CNS water channel, and is called hereon "NMO/AQP4-IgG". Among neural cells, AQP4 is restricted to astrocytes. NMO/AQP4-IgG is H60% sensitive and H99% specific for relapsing NMO, a severe recurrent inflammatory demyelinating disease that preferentially affects optic nerves and spinal cord. Throughout the 20th century NMO (Devic's Disease) was considered a variant of multiple sclerosis (MS). Clinical, radiological, pathological and serological correlative observations reported by the Mayo NMO Consortium in the past 4 years, and now confirmed internationally, indicate that this is not the case and that NMO and MS are distinct diseases. No biomarker has been validated for MS. We also recognize that autoimmunity targeting the astrocytic AQP4 water channel is the basis of a broader spectrum of CNS disease (the "NMO spectrum") than described by Devic in 1894. AQP4 autoimmunity represents a pivotal new direction in CNS demyelinating disease research. Despite the high frequency of NMO/AQP4-IgG in sera of patients with relapsing NMO, H40% of patients are seronegative. Our cumulative clinical, therapeutic and immunopathologic observations suggest that seronegative NMO also is an IgG- mediated disorder. Our preliminary serological data support the existence of alternative pathogenic NMO-IgGs targeting other antigenic components of the AQP4/dystroglycan complex. The Mayo NMO Consortium is an interdisciplinary group of scientists and physicians who, through complementary interests, coalesced in the past decade to jointly investigate NMO. This group is uniquely qualified to undertake the translational investigations we now propose because: 1) Mayo Clinic is an acknowledged center of excellence for NMO diagnosis, treatment and research, with state-of-art clinical and research infrastructure; 2) all collaborating neurologist and bench investigators have a focused commitment to discovering the cause and mechanisms of AQP4 autoimmunity and developing new and improved treatment strategies; 3) NMO-IgG testing, performed in the Department of Laboratory Medicine and Pathology on a service basis (10,000 patients annually), currently identifies on average 70 new seropositive patients in the USA monthly. Interpretive contact with the attending physicians of these patients by our Neurology Fellows and Consultants, facilitates ascertainment of study subjects for this study; 4) the clinical-serological database of NMO/AQP4-IgG-positive patients created in the Clinical Neuroimmunology Laboratory in 2003 for quality assurance purposes is now complemented by a NMO clinical-serologic repository (funded by the Guthy- Jackson Charitable Foundation), providing a dynamic and unparalleled IRB-approved infrastructure for the research we propose. We will test 3 hypotheses: Hypothesis 1: CNS demyelinating disorders accompanied by NMO/AQP4-IgG are not rare, disproportionately affect ethnic minorities and are often misdiagnosed as MS. Hypothesis 2: Serum NMO/AQP4-IgG is significant prognostically and guides optimal therapy. Hypothesis 3: IgGs targeting novel components of the AQP4-dystroglycan complex ("termed NMO-IgG X") account for a subset of NMO patients who are NMO/AQP4-IgG seronegative. Our Specific Aims address these 3 hypotheses: Aim 1. To determine the seroprevalence of NMO/AQP4-IgG in ethnically diverse patients (African American, Afro-Caribbean, African, Asian, Caucasian, Hispanic and American Indian) who carry diverse CNS inflammatory demyelinating disease diagnoses including NMO, transverse myelitis, optic neuritis, MS, and acute disseminated encephalomyelitis. Aim 2. To assess the predictive and prognostic value of immunochemical and functional NMO/AQP4- IgG assays (complement activation, AQP4 downregulation and coupled glutamate transporter down- regulation) and assays determining antibody affinity for AQP4. We will investigate potential correlations between individual patient's clinical phenotype (disability, relapse rate, attack severity [vision loss, paraplegia] or extent of recovery) and 1) serum levels of NMO/AQP4-IgG (measured by immunofluorescence [IF], immunoprecipitation [IP] and ELISA assays); 2) quantitative functional effects of patient serum on AQP4- expressing cells (primary astrocytes, transfected HEK 293 or MDCK cells) and 3) NMO/AQP4-IgG concentration, affinity and binding kinetics (evaluated using surface plasmon resonance [BIAcore system]). Aim 3. To investigate novel IgG biomarkers (NMO-IgG X1, X2,...) as the potential basis of NMO in apparently seronegative patients. We will use cell-based functional assays and IP analyses to search for alternative autoantibody specificities in NMO/AQP4-IgG-seronegative patients.